Core A: Determining and targeting mechanisms controlling cancer cell division

PROJECT SUMMARY
Gain-of-function mutations of oncogenes and loss-of-function mutations of tumor suppressor genes drive the
initiation and progression of human cancer. These genes also play critical roles in normal development and
cellular differentiation. Genetic or epigenetic alterations in the Rb pathway are required for the initiation and
progression of most types of human cancer. The three inter-related projects in this program will address major
outstanding fundamental questions about the functioning of key proteins in the Rb pathway: Cyclin D-Cdk4/6
oncoproteins that regulate Rb by phosphorylation, the Rb family of tumor suppressors that act as transcriptional
regulators, and the E2F family of transcription factors that interact with and are directly regulated by the Rb family
proteins and control the transcription of genes important for cell cycle progression. A major goal of this program
project is to investigate the Rb pathway using an interdisciplinary approach. The major goal of this Core is to
provide an administrative framework to help implement the scientific goals and disseminate the results of the
proposed experiments.
Specifically, the Administrative Core will have three goals. The first goal will be to promote scientific interactions
among the Project Leaders and laboratory members involved in the three main Projects and two Scientific Cores.
The second goal will be to provide scientific and financial guidance and oversight, including in conjunction with
an Internal Advisory Committee and an External Scientific Advisory Board. The third goal will be to facilitate
communication among the members of the Projects and Cores themselves and to the greater scientific
community and the public. To achieve these goals, the Leader for this Administrative Core, will work closely with
the Leaders of each of the Projects and Scientific Cores. Regular scientific interactions to exchange ideas and
results, feedback from members of the internal advisory committee and the external scientific advisory board,
and specific metrics to monitor progress, will all be critical to help uncover novel fundamental mechanisms
underlying cell cycle progression.

Public health relevance
PROJECT NARRATIVE The overall program will study a genetic pathway that controls cell cycle progression and that is frequently mutated in human cancers. The function of the Administrative Core will be to promote scientific interactions among the Project Leaders and Core Leaders and their laboratory members, to provide guidance and oversight, and to facilitate communication among the members of the Projects and Cores, the greater scientific community, and the public. A long-term goal of this program is to help guide the development of new drugs for the treatment of human cancer.